Clinical Research Core

PROJECT SUMMARY - CLINICAL RESEARCH CORE
The mission of the Center for Gastrointestinal Biology and Disease is to catalyze multidisciplinary research on
various aspects of clinically relevant gastrointestinal biology, pathophysiology, and epidemiology to reduce the
burden associated with digestive disease. The Clinical Research Core is fundamental to accomplishing that
mission. The Core assists with study design and logistics, as well as the collection, analysis and integration of
biological and epidemiological data using techniques of computer science and statistics. Under the direction of
Evan Dellon, MD, MPH, an experienced clinical, epidemiologic, and translational researcher, the core assists
with database implementation and maintenance, web applications, validated and secure data capture, quality
control, data analysis, and statistical analysis. The core offers full collaboration on sound statistical study
design, study process engineering, data model development, system design and implementation. This leads to
secure and accurate data capture and management, linking of various data types and sources, and data
extraction and reporting for analytics. The Core provides an interface between basic scientists and informatics
specialists to support translational research. The Core provides essential services to the large group of clinical
epidemiologists who are members of our Center. The clinical research component of the core includes
assistance with study start-up, IRB approval, IND, regulatory issues, contracting, clinical coordinator staffing,
data and specimen collection, specimen processing, quality control and monitoring. The specific aims of the
core are: 1) To provide consultation on biostatistics and study methodology during the design, conduct and
analysis phases of research. 2) To offer data collection and data management services including forms
development, enrollment tracking, data capture, data validation, data security and confidentiality, database
closure, statistical programming, and application development. 3) To allow access to large claims databases
such as IQVIA Pharmetrics, IBM MarketScan and Medicare. 4) To support clinical and translational
research through regulatory support, contract negotiations, and data and specimen collection and cataloguing
provided by a team of experienced study coordinators. 5) To deliver training and education about sample
size and power calculations, study design and analysis.